Advancing primate models of human auditory cognitive control

Abstract
The development of more powerful primate models of auditory cognitive control is critical for
advancing understanding of the cognitive and neural systems underlying the capacity for human
communication. Valid models depend on identification of which aspects of these systems are
present in monkeys. The long-term goal of this work is to better understand the relations
between auditory cognitive control in humans and primates, enhancing the utility of primate
models for research on auditory-communicative disorders. The overall objective of this
application is to identify some aspects of auditory cognitive control in humans that can be
modeled in primates. The central working hypothesis is that the same experimental techniques
used to establish visual cognitive control can also elucidate components of auditory cognitive
control. The rationale is that valid behavioral models of auditory cognitive control in primates are
foundational for studies of the relevant neural systems, and ultimately for developing and testing
novel treatments for individuals with communication disorders. The central hypothesis will be
tested by accomplishing three specific aims: (1) Use tests that are diagnostic of working
memory to determine which components of human auditory working memory can be modeled in
rhesus monkeys, (2) Assess cognitive control of auditory attention and decision-making in
monkeys, and (3) Evaluate a putative neural substrate of auditory cognitive control using
comparative studies across humans, orangutans, and monkeys. For the first aim, whether
monkeys engage in active maintenance of information in auditory working memory will be tested
using competing cognitive load and directed forgetting manipulations in auditory memory tests.
For the second aim, control of auditory attention will be evaluated using tasks that require
flexibly focusing auditory attention and filtering auditory distractors. Cognitive control of
decision-making will be evaluated using tests of adaptive information-seeking. For the third aim,
auditory cognitive abilities will be compared across monkeys, orangutans, and humans to
evaluate the putative correlation between these skills and expansion of the dorsal auditory
pathway. The proposed research is innovative because it uses novel tests of auditory working
memory, attentional control, and adaptive decision-making that specifically dissociate these
processes from non-controlled, passive, or automatic mechanisms. The work also achieves a
systematic comparison of auditory memory across primates using equivalent tests. The
proposed research is significant because it is expected to provide a robust foundation for future
biomedical research on auditory-communicative deficits using proven primate models.

Public health relevance
Narrative The proposed research is relevant to public health because it develops better primate models of auditory cognitive processes critical for language in humans. By identifying shared components of auditory working memory, attentional control, and strategic decision-making in primates and humans, this work will enable researchers to use primates in basic and interventional studies. Thus, the proposed research is relevant to the part of the NIDCD’s mission that pertains to biomedical research on processing of speech and language.